Designing a novel post-incident intervention to address patient harassment of staff in VA primary care settings

Project Background: Ninety-seven percent of women and 77% of men internal medicine physicians in a
recent Veterans Affairs (VA) healthcare facility survey reported sexual harassment from patients. Staff may
cope with patient-perpetrated harassment by omitting elements of care, rushing clinical tasks, and distancing
from the patient emotionally and physically. Further, patient-perpetrated harassment is associated with
decreased staff well-being and increased burnout and turnover, which are in turn associated with decreased
quality of care, decreased patient satisfaction, and increased risk of medical errors. Secretary McDonough
recently vowed to end all forms of harassment and discrimination at VA, and the new Deborah Sampson Act
requires facilities to implement anti-harassment procedures. However, prior work indicates that VA lacks
systematic, evidence-based interventions for responding to patient harassment of staff that anticipate
harassment, stop the incident, communicate that harassment is unwelcome, facilitate incident reporting, and
support affected staff. The goal of this pilot project is to design a novel intervention to guide immediate post-
incident staff, clinic, and facility responses to patient-perpetrated sexual harassment of staff in primary care.
Significance/Impact: The resulting intervention will address ORD Strategic Priority 4: actively promoting
diversity, equity, and inclusion by communicating that VA does not tolerate harassment based on social identity
characteristics. Additionally, it will contribute to HSR&D priority domain: Primary Care Practice and Complex
Chronic Disease Management by offering support related to patient-perpetrated harassment that can “improve
provider and staff morale,” improve staff-provider interactions, and increase quality of patient care.
Innovation: This pilot project leverages a unique opportunity to respond to unprecedented leadership and
policy support for interventions to address harassment at VA. The resulting intervention will fill a critical gap in
procedures grounded in empirical data for responding to patient-perpetrated harassment and supporting VA
staff, and will complement VA’s ongoing anti-harassment efforts. Our design process will be guided by an
innovative framework that will ensure that the intervention fits with VA priorities and stakeholder needs.
Specific Aims: The Specific Aims are to: 1) identify intervention components based on existing and ideal
practices for responding to patient-perpetrated harassment of staff; and 2) refine the post-incident intervention
through iterative stakeholder feedback.
Methodology: Guided by a Steering Committee of operations partners, VA leadership, and subject matter
experts, we will follow a step-based process of transcreation, i.e., co-designing interventions with stakeholders
to fit with local contexts from the outset. We will focus on primary care settings, which have established rates of
harassment and serve as the main port of entry into VA care. We will achieve Aim 1 by interviewing VA primary
care providers (e.g., physicians, medical trainees), supervisors (e.g., primary care chiefs, fellowship
preceptors), leaders (e.g., facility directors, fellowship directors), and other subject matter experts (e.g.,
ethicists, disruptive behavior committee members) (n = 30) to elicit current and desired staff, clinic, and facility
procedures for responding to patient harassment and supporting affected staff. We will achieve Aim 2 by a)
engaging an expert panel of Steering Committee members and Aim 1 staff participants (n = 12) in a modified
Delphi process to build consensus on importance and feasibility of intervention components identified in Aim 1;
and b) conducting interactive webinars with staff from Women’s Health Practice-Based Research Network sites
to assess likelihood of intervention adoption and potential adoption barriers.
Implementation/Next Steps: Following project completion, we will seek HSR&D funding to test the
intervention in an effectiveness-implementation trial, with the ultimate goals of adaptation to other clinical
settings and forms of patient-perpetrated bias (e.g., racial/ethnic discrimination) and dissemination.

Public health relevance
Patient sexual harassment of staff is common in Veterans Affairs (VA) healthcare facilities. Patient harassment of staff reduces quality of care; negatively impacts staff wellbeing, burnout, and turnover; and contributes to an environment that tolerates other forms of harassment (e.g., toward women patients) and discrimination (e.g., based on race/ethnicity). Recent VA anti-harassment campaigns focus on harassment prevention, but additional work is needed to help staff respond to and cope with experiences of harassment when they occur. This pilot project will engage VA staff, leaders, and other stakeholders in the co-design of an intervention to guide immediate staff, clinic, and facility responses to patient harassment of staff in primary care settings, which serve as the entry point into VA care. The resulting intervention has the potential to increase staff well- being and quality of patient care, bolster ongoing anti-harassment efforts, and create a safe, respectful environment of care in which harassment is not tolerated.